Administrative supplement to purchase a MerMade 4 oligonucleotide synthesizer for the large-scale production of modified RNA substrates

ABSTRACT:
Our NIH R35 ESI MIRA entitled ‘Selectivity and regulation of mRNA demethylation by iron-
dependent dioxygenases’ focuses on understanding the structural and molecular determinants of
AlkBH-family RNA demethylase enzymes that play key roles in RNA function and some human
cancers. A critical challenge to carrying out some of the proposed structural experiments has
been in obtaining sufficient quantities of modified RNA oligonucleotide substrates for
crystallographic screening and biophysical binding assays. This administrative supplement
requests funds to purchase an LGC MerMade 4 oligonucleotide synthesizer that will transform
and greatly accelerate our ability to access key modified RNA oligonucleotide reagents to support
multiple goals of our MIRA projects.

Public health relevance
PROJECT NARRATIVE Major goals of our parent R35 ESI MIRA include the structural and functional characterization of mRNA demethylases and their selectivity toward different methylated RNA nucleobases. A critical hurdle to accomplishing the structural and biophysical experiments needed to understand demethylation selectivity at high resolution has become production of large amounts of modified RNA oligonucleotides. This administrative supplement proposal requests funds to purchase an LGC MerMade 4 oligonucleotide synthesizer that will drastically increase our ability to obtain micromole-scale modified RNA substrates for protein crystallography and biophysical binding assays, which are essential for characterizing modified RNA-enzyme interactions and the successful completion of our MIRA project goals.